South Texas Advanced Research Training: Undergraduate Program (START-UP)

DESCRIPTION (provided by applicant): The proportion of underrepresented minorities (URMs) earning doctorate degrees in the basic biomedical sciences has increased modestly over the past few decades. Our proposed Program, the South Texas Advanced Research Training Undergraduate Program (START-UP) is a response to a Funding Opportunity Announcement from the Blueprint Program for Enhancing Neuroscience Diversity through Undergraduate Research Education Experiences (BP-ENDURE). As such, the overall goal of our Program is to encourage and prepare junior and senior undergraduate URMs from the San Antonio and South Texas Region to enter doctoral programs in neuroscience, to complete them successfully, and become well-trained and competitive neuroscientists. To accomplish this, a comprehensive program is proposed for the URM students accepted into the program, involving extensive research experiences in the laboratories of successful neuroscientists, and opportunities to develop and improve their writing, speaking, and time management skills. Students will be recruited into START-UP from five partner institutions in San Antonio, namely Our Lady of the Lake University, St. Mary's University, Trinity University, University of the Incarnate Word, and the University of Texas, San Antonio. Collectively these schools have 24,527 undergraduates who are URMs (based on ethnicity), of whom 2,947 are Science Majors. Also, these schools have a high number of students from low income families, many of whom are the first in their families to attend college. Faculty contacts have been established at each school to assist us recruit suitable students into START-UP. Thirty-one training faculty have been identified (including three from UTSA), who are appropriate to mentor these students in their laboratories. The students will participate in laboratory research for an average of 12 hours per week during the two academic semesters, and 40 hours/week during a 10-week intensive summer research exposure. Students will also have an opportunity to work in one of seven major neuroscience programs at institutions outside of San Antonio during the summer. In addition to their laboratory research, the students will also attend seminars and journal clubs, research retreats, and have exposure to neuroscientists from other institutions. The students will all receive instruction on the responsible conduct of research. The Co-Directors of the Program are Drs. Alan Frazer and David Weiss, experienced scientists and administrators, who have run programs similar to START-UP previously. They will be members of an Executive Committee that will oversee all aspects of the Program. There is a formal evaluation plan for the Program, as well as an outcomes assessment process. Further, a plan is described to disseminate nationally all materials developed for the design and implementation of START-UP.

Public health relevance
PUBLIC HEALTH RELEVANCE: The number of underrepresented minorities (URMs) in the biomedical sciences remains woefully inadequate, and the proportion of URMs earning doctorate degrees in the basic biomedical sciences has increased very modestly over the past few decades. Our proposed Program, the South Texas Advanced Research Training Minority Undergraduate Program (START-M-UP) is a response to the Funding Opportunity Announcement from the Blueprint Program for Enhancing Neuroscience Diversity through Undergraduate Research Education Experiences (BP-ENDURE). As such, the overall goal of our Program is to encourage and prepare junior and senior undergraduate URMs from San Antonio and the South Texas Region to enter doctoral programs in neuroscience, to complete them successfully, and to become well-trained and competitive neuroscientists. Narrative The number of underrepresented minorities (URMs) in the biomedical sciences remains woefully inadequate, and the proportion of URMs earning doctorate degrees in the basic biomedical sciences has increased very modestly over the past few decades. Our proposed Program, the South Texas Advanced Research Training Minority Undergraduate Program (START-M-UP) is a response to the Funding Opportunity Announcement from the Blueprint Program for Enhancing Neuroscience Diversity through Undergraduate Research Education Experiences (BP-ENDURE). As such, the overall goal of our Program is to encourage and prepare junior and senior undergraduate URMs from San Antonio and the South Texas Region to enter doctoral programs in neuroscience, to complete them successfully, and to become well-trained and competitive neuroscientists. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Our overall goal is to encourage and prepare undergraduate underrepresented minorities (URMs) to enter doctoral programs in neuroscience, to complete them successfully, and become well-trained and competitive neuroscientists. We intend to excite these students about neuroscience such that they will understand that being a professional neuroscientist is a rewarding career path. To achieve this, our specific aims are: 1) To help our students build a foundation for becoming a successful neuroscientist. We will evaluate and help them to develop many of the characteristics necessary to compete successfully for admission into graduate programs, and to ultimately go on to successful careers, e.g. ability to think creatively, work ethic, ambition, ability to express ideas in written and oral form, etc; and we will identify strategies for each student to help them improve in these areas, to be more competitive when applying to graduate school. These assessments and progress will be documented in formal evaluations of their performance in the labs, and from the written papers and oral presentations mandated after each period of research activity. Assessments and progress in all of these areas will be discussed with the students individually at each stage of the program. 2) To allow the students to gain confidence in their research abilities and to enjoy research. This will be achieved by initially giving them projects that are "doable", and by having the undergraduates work closely with graduate students or postdoctoral fellows in their laboratories. They will be given more independence in their second and subsequent research projects, consistent with the abilities they developed during their prior research experiences. 3) To allow the students to observe and experience what life is like as a graduate student, learning to balance research responsibilities, coursework, professional development activities and a social life. 4) To advise the students, in consultation with the faculty contacts at their schools, about the number, level, and sequence of science courses they should take to be competitive for graduate school programs in the neurosciences and to make certain that they take a professional GRE preparatory course no later than the beginning of their senior year. To have the students interact with faculty from other institutions so as to gather information about a variety of graduate programs and the criteria for acceptance into such programs. 5) To experience the breadth, as well as the excitement and camaraderie among professionals in the field of neuroscience, we will have the students attend at least one national neuroscience meeting during their time in the Program and, if appropriate, be an author on a paper or poster being presented at the meeting. 6) To increase the number of URM students from the South Texas Region who apply successfully to doctoral programs in Neuroscience. More broadly, but equally important, our goal is to provide a meaningful and enriching experience that will make it possible for ALL of the students to make an informed decision and to feel a sense of empowerment regarding their future career directions, whatever they may ultimately be.